Statistical approaches to improving functional connectivity estimates with an application to autism

ABSTRACT
Functional magnetic resonance imaging (fMRI) is used to estimate the correlations between brain regions. De-
spite the many insights into brain function provided by fMRI, the ﬁeld is currently experiencing a reproducibility
crisis. For instance, autism spectrum disorder (ASD) is thought to be the result of disordered brain connections,
but the ASD literature contains conﬂicting reports of both hypo- and hyper-connectivity. Participant head motion
is a crucial factor, and the exclusion of high-motion participants can reduce the impacts of motion. However,
motion quality control removes more than 50% of data in pediatric fMRI studies. In ASD, the most severely im-
paired children tend to be removed – we are characterizing a limited part of the autism spectrum. In addition,
methodological development and empirical studies have focused on functional connectivity measured at rest.
Children move less during some tasks, such as watching a movie. Dynamic connectivity during a task may offer
crucial insights into diseases of brain connectivity with larger effect sizes, but popular methods do not utilize task
information during model ﬁtting. The overall objective of this grant is to develop statistical methods that decrease
bias and improve efﬁciency in functional connectivity studies. Our proposal is motivated by a resting-state fMRI
study on ASD with hundreds of children from the Kennedy Krieger Institute and Johns Hopkins University. We
will assess external validity in an independent test dataset that will be collected at the Marcus Autism Center and
Emory University, where we will also conduct a study of engagement during a movie with social interactions. To
achieve our objective, we propose the following: 1) Develop a missing data method for deconfounding to reveal
functional connectivity signatures of ASD. This aim addresses sampling biases due motion quality control. 2)
Develop a causal mediation framework for signal decomposition of functional connectivity and motion. This aim
will be used to disentangle neural versus motion contributions to function connectivity in ASD. 3) Develop a novel
covariance regression model for dynamic functional connectivity during a task. This aim will test the scientiﬁc
hypothesis that the neural underpinnings of engagement differ in children with ASD compared to typically devel-
oping children. We will develop software so that the proposed methods can be broadly applied to neuroimaging
studies including neurological disorders and mental health. Completing these aims will 1) provide tools that will
improve reproducibility in functional connectivity studies and 2) reveal the neural underpinnings of ASD. This can
aid in the development of treatments and educational strategies.

Public health relevance
PROJECT NARRATIVE Functional magnetic resonance imaging is a popular tool in studies of neurodevelopmental disorders, but re- producibility is a major issue, in part due to biases and inefﬁciencies related to head motion during MRI collection. We develop statistical methods that account for issues created by head motion, and we propose a model for brain dynamics during a task. We conduct a reproducibility study to learn how the brain functions in autism spectrum disorder and develop tools that can be used by other research groups to improve our understanding of brain disorders.